Pilot and Feasibility Program

Project Summary/Abstract - Pilot and Feasibility Program
The purpose of the Michigan Diabetes Research Center (MDRC) Pilot and Feasibility (P/F) Grants Program
is to stimulate new research in the areas of diabetes, its complications, and related endocrine and metabolic
disorders. This research may be in areas of basic biomedical science or clinical research. This program
provides a minimum of $250,000 per year for P/F grant awards; additional funding may be provided for
highly-rated applications using funds provided by the University of Michigan. The MDRC P/F program will
fund two types of awards: (1) standard one-year $50,000 P/F awards with a single PI, and (2) two-year, $100,000
Diabetes Interdisciplinary Studies Program (DISP) awards that seek to support and promote new
collaborations between two or more University of Michigan (UM) faculty members from distinct disciplines,
to focus their combined research strengths on cutting-edge areas in diabetes research. Each year, the
MDRC solicits applications for P/F and DISP grants from full-time instructional or research faculty at UM.
Those eligible include: 1) new investigators without past or current NIH research support who are beginning
careers in diabetes research, 2) established investigators who have not previously worked in diabetes
research but wish to focus their expertise on diabetes, and 3) established diabetes investigators who
propose innovative research in diabetes that represents a clear departure from their ongoing research.
Highest priority is given to new investigators. Applications are actively solicited from across the university
and are peer-reviewed by two or more extramural reviewers with expertise in the area of the application.
Grant applications with the highest merit, as judged by this review process and the intramural Grants
Program Advisory Council, receive awards. The balance of standard P/F and DISP awards may vary from year
to year, depending upon the relative strength of applications for each award type. The ultimate goal of the
program is to enable awardees to generate sufficient preliminary data to support a successful application for
major research funding from the NIH or another national granting agency. The P/F Grants Program attracts
investigators from diverse schools, departments, and institutes into diabetes research and fosters new,
innovative, interdisciplinary, and collaborative diabetes research at UM.